IMPACT Project 2 – The impact of clinic-level financial incentives on HPV vaccine communication and uptake

ABSTRACT – Project 2
Human papillomavirus (HPV) vaccination is effective and recommended to protect against six types of
cancer, but HPV vaccine coverage remains low. Provider communication has a powerful influence on HPV
vaccine uptake. Our program team has demonstrated that Announcement Approach Training (AAT) effectively
improves provider communication and increases HPV vaccination uptake. A promising tool to expand the
impact of AAT is clinic-level financial incentives, which can motivate providers to apply what they learn in the
AAT workshop. Financial incentives are increasingly a central part of payment reform efforts focusing on better
aligning financial incentives in healthcare systems with quality of care. No studies have adequately established
whether financial incentives motivate providers to recommend HPV vaccination. As part of the proposed P01
Program Project, “Improving Provider Announcement Communication Training (IMPACT),” the goal of this
randomized clinical trial (RCT) is to test promising alternatives to motivate providers to improve HPV vaccine
communication. We propose to examine whether financial incentives tied to clinic-level improvement in HPV
vaccination rates can improve HPV vaccine communication and uptake. To achieve this goal, in Aim 1, we
will characterize providers’ perceptions of financial incentives tied to HPV vaccination and behavioral
nudges via a national primary care team survey. We will also refine a feedback report to track HPV
vaccination rates paired with improvement targets to providers and clinics. In Aim 2, we will conduct the
RCT, randomizing clinics to one of two arms: 1) AAT and 2) AAT plus financial incentive tied to clinic-level
improvement in HPV vaccination rates. In Aim 3, we will evaluate intervention implementation, including
cost per additional adolescent initiating HPV vaccine. This RCT is significant because it will demonstrate
whether and how financial incentives improve provider communication and increase vaccine uptake to achieve
HPV vaccination goals. The proposed research addresses the IMPACT Program Project theme of amplifying
the impact of a Research-Tested Intervention Program to improve HPV vaccine communication in healthcare
systems via financial incentives to motivate providers to make needed recommendations.

Public health relevance
NARRATIVE – Project 2 Our goal is to rigorously test promising alternatives to motivate providers to improve human papillomavirus (HPV) vaccination communication and HPV vaccination rates in healthcare systems. The proposed randomized clinical trial will demonstrate whether and how financial incentives improve provider communication and increase vaccine uptake to achieve HPV vaccination goals.